Developmental Core

IN-TRAC DEVELOPMENT CORE ABSTRACT
The Development Core will establish a culture of continuous education and development for IN-TRAC
participants that are new or established new to the TB field. This includes career development training in lab
management, grant writing and community engagement, and tailoring the research and clinical experiences to
develop TB researchers that are adaptable to the changing landscape of future research and clinical needs. IN-
TRAC participants will work within a values-driven, research intensive institute and carefully selected unique,
established field sites. The Development Core will award pilot grants to IN-TRAC participants to support
multidisciplinary collaborative research, or preliminary and feasibility data for federal and non-federal grant
submissions or project development. Specifically, the Development Core proposes: AIM 1: Facilitate multi-
disciplinary training experiences for each individual IN-TRAC participant. IN-TRAC participants will
accomplish this through intern and extern programs that will introduce them to a spectrum of multifaceted
research tools that will be required to address some of the most complex challenges related to understanding,
treating or preventing TB. AIM 2: Develop IN-TRAC talent through a program of continuous learning and
campus culture. IN-TRAC participants will be exposed to a training program that covers many of the soft skills
and intangibles that are needed to develop a highly competitive, collaborative and multidisciplinary research
career. AIM 3: Establish a pilot grant program that supports multidisciplinary science. IN-TRAC
participants will be eligible for pilot grants to develop independent research programs for their first federal and/or
non-federal TB grant applications, to bring new technologies to their laboratories, or to develop collaborative
multi-disciplinary programs that will increase opportunities for large programmatic grants related to TB research.
At completion, IN-TRAC participants will understand many of the most significant clinical problems for TB
detection, surveillance, treatment and prevention. This will be combined with the confidence to move across
multiple disciplines and with skills to communicate science effectively to ensure that their TB research is funded,
developed, implemented and known worldwide.